Targeting ACOD1 to attenuate innate immune responses to lethal infections

ABSTRACT
A leading cause of microbial infections in hospitalized patients is Gram-negative bacteria, which release the
cell wall component lipopolysaccharide (LPS) capable of activating innate immune pathways. The aconitate
decarboxylase 1 (ACOD1) is an LPS-inducible mitochondrial enzyme that was previously implicated as a
negative innate immune regulator through catalyzing the production of anti-inflammatory itaconate. However, we
recently demonstrated that the LPS-induced ACOD1 up-regulation also confers a robust pro-inflammation
response in monocytes and macrophages in an itaconate-independent manner. Genetic deletion of ACOD1 or
its upstream signaling CDK2 in myeloid cells or pharmacological inhibition of CDK2 (with dinaciclib) uniformly
attenuated infection-induced cytokine storm and animal lethality in pre-clinical setting. Clinically, the CDK2-
ACOD1 axis was similarly up-regulated and positively correlated with the severity of bacterial infections in a
cohort of 40 patients. Thus, our findings have suggested a novel role for ACOD1 in promoting dysregulated
innate immune responses to lethal infections. Our central hypothesis is that ACOD1 exerts pro-inflammatory
action through interacting with other effectors such as GIMAP7. To test this hypothesis, we will exploit a
multifaceted strategy to pursue the following integrated aims. Aim 1: Define the adaptor proteins responsible for
CDK2-mediated ACOD1 upregulation in monocytes and macrophages. Aim 2: Identify the effectors responsible
for ACOD1-mediated pro-inflammatory cytokine production in monocytes and macrophages. Aim 3: Evaluate
the efficacy of anticancer drugs in disrupting ACOD1/GIMAP7 interaction and fighting against lethal infections in
preclinical settings. The completion of these studies will provide new insights into the intricate mechanism
underlying infection-induced innate immune dysfunction and shed light on the development of novel therapeutic
strategy for the management of lethal infections.

Public health relevance
PROJECT NARRATIVE A leading cause of microbial infections in hospitalized patients is Gram-negative bacteria, which release the cell wall component lipopolysaccharide capable of activating innate immune pathways. We postulate that ACOD1 is a mediator of lethal bacterial infection independent of its canonical function in itaconate production. Our research could not only provide new therapeutic targets for infectious diseases, but also establish promising uses for anticancer drugs in limiting inflammatory responses.